Impact of preanalytical conditions on functional cancer biomarkers

PROJECT SUMMARYABSTRACT
An attractive approach to improve the survival of ovarian cancer patients is to identify the ideal therapy for each
tumor. Functional precision medicine (FPM) represents an emerging class of biomarker where the ideal therapy
is selected by directly exposing patient tumor cells to potential drug options followed by molecular or phenotypic
measurement of drug response. Ideally, FPM biomarkers require viable patient cancer cells that are also
phenotypic surrogates of the patient tumor. However, the impact that different pre-analytic tumor handling
protocols have on the fidelity and output of FPM biomarkers remains poorly understood.
Here, we propose to identify optimal pre-analytic tumor handling conditions for a FPM biomarker. The FPM
biomarker used in this proposal is ramp up dynamic BH3 profiling (RUDBP) which measures whether a rapid (2-
16 hour) exposure of chemical libraries induces apoptotic signaling in cancer cells. Importantly RUDBP can be
performed on samples with low cell numbers to evaluate drug sensitivity such as core needle biopsies. In this
proposal, using human surgical resections and patient derived xenografts, we will measure how pre-analytic
tumor handling alters RUDBP. Specific pre-analytic handling conditions include live tumor transport conditions
(Aim 1), long-term frozen storage conditions (Aim 2), and pre-analytic ex vivo expansion culture conditions (Aim
3). In each aim we also seek to correct pre-analytic artifacts using mathematical models to align RUDBP of the
handled tumor to RUDBP of the fresh tumor.
The proposed studies will systematically establish optimal tumor handling conditions for RUDBP by identifying
ideal live tumor transport conditions, frozen storage conditions and pre-analytic ex vivo cell culture conditions.
We anticipate that careful analysis of pre-analytic conditions will minimize potential false results of functional
biomarkers. Finally, we expect that these results will accelerate incorporation of FPM into the clinic, increase
accessibility for patients at distant sites, and ultimately aid in identifying ideal therapies for relapsed and refractory
ovarian cancer patients.

Public health relevance
PROJECT NARRATIVE: Functional biomarkers represent a promising class of tools to identify the ideal drug for individual patients who have poor clinical options. Nonetheless, the impact of pre-analytic tumor handling on the performance of functional biomarkers remains poorly understood. Here, by identifying the optimal pre-analytic tumor handling conditions for a functional oncology biomarker and correcting pre-analytic artifacts, we aim to develop standard protocols that will increase the accuracy and reproducibility of these biomarkers.